Pittsburgh Girls Study: Substance Use and HIV Risk Behaviors/STI in Young Adulthood

ABSTRACT This 1-year supplement to the Pittsburgh Girls Study (PGS), a large longitudinal community study of young adult women, will capture urgently needed data on factors at individual (e.g., smoke or vape tobacco/nicotine, cannabis), social (family, peer), and neighborhood (e.g., perception of neighborhood disorganization) levels associated with increased risk for COVID-19 infection and illness progression, particularly among young adult women who smoke or vape tobacco or cannabis. Data to be collected with supplemental funds will add new COVID-19 items to the PGS’s 20th annual wave (web survey) in the two youngest cohorts (ages 24-25; N=1,048; 56% Black, 37% White), to be fielded in early June 2020, after the estimated peak in COVID-19- related mortality in Pennsylvania. New COVID-19 items will assess symptoms and related testing and health care (e.g., barriers to care, insurance), beliefs regarding transmission and personal infection risk, infection prevention behaviors, and the broad impacts of COVID-19 on quality of life (e.g., job loss, food insecurity). New COVID-19 items to be included in wave 20 will add to 19 annual waves of PGS data collected since childhood on substance use/disorder (SUD), physical health (e.g., diabetes, asthma, obesity, cardiovascular disease) and healthcare, mental health, personal (e.g., employment, resilience), and environmental (e.g., geocoded data) risk and protective factors associated with risk for sexually transmitted infection/HIV (parent R01). This supplement aims to: (1) investigate differences by race among Black and White young women in pathways of risk and protection for COVID-19 infection and progression at individual (e.g., smoking and vaping behavior; perceived risk for and behaviors to prevent COVID-19 infection), social (e.g., extent and duration of social distancing), and neighborhood levels (e.g., perceived community cohesion, census tract population density); and (2) examine impacts of COVID-19 on women’s substance use/SUD, access to and use of COVID-19- related health care, physical and mental health (e.g., response to stress/traumatic event), employment and financial status, and interpersonal relations (e.g., effects of social distancing). Results from this 1-year supplement have implications for addressing racial disparities in risk for COVID-19 infection and its broad impacts, in the context of COVID-19’s intersection with substance use/SUD (particularly smoking/ vaping tobacco, cannabis), among women, an understudied population, to guide effective and equitable public policy.

Public health relevance
PROJECT NARRATIVE This 1-year supplement to the Pittsburgh Girls Study (PGS), a large longitudinal community study of young adult women (ages 24-25; 56% Black, 37% White), will capture urgently needed data on factors at individual, social (family, peer), and neighborhood levels to identify factors associated with increased risk for COVID-19 infection and illness progression, particularly among young women who smoke or vape tobacco or cannabis. Data to be collected in PGS’s 20th annual wave in the two youngest cohorts will provide a unique opportunity to examine racial differences in risk for COVID-19 and its intersection with substance use, as well as COVID- 19’s broad impacts on quality of life among women, an understudied group, to inform equitable public policy.